Type I interferon dependent and independent roles of IL-27 in Sjogren's

PROJECT SUMMARY
Sjögren’s, an autoimmune disease that targets the lacrimal and salivary glands, is estimated to affect 4 million
Americans. The absence of adequate early diagnostics contributes to the lack of effective therapies to halt or
limit the autoimmune process. Thus, patients are diagnosed after extensive damage to the glands and
experience: profound ocular and oral dryness with potential for vision-threatening complications, poor oral
health; extra-glandular manifestations that may affect nearly any organ; profound pain and fatigue; and an
increased risk of lymphoma. There is a critical need to understand the early mechanisms that contribute to
lacrimal and salivary gland autoimmunity. The long-term goal of our research is to define the mechanisms that
lead to the initial inflammation of the lacrimal and salivary glands to promote reliable early diagnostics and
effective therapeutic targets. IL-27 is a pleiotropic cytokine with both proinflammatory and anti-inflammatory
roles depending on context. Recently, IL-27 was shown to be highly elevated in the saliva of pediatric Sjögren
patients. IL-27 is a heterodimeric cytokine composed of p28 and Epstein-Barr virus Induced 3 (EBI3) and
signals through a heterodimeric receptor which comprises IL-27Rα and gp130. It is produced by dendritic cells
(DCs), monocytes, macrophages, and B cells. Type I interferon (IFN) signaling can drive IL-27 production, but
recent data also suggest IL-27 can drive upregulation of type I IFN-stimulated genes even in the absence of
type I IFN signaling. Nonobese diabetic (NOD) mice spontaneously develop exocrine gland autoimmunity
similar to human Sjögren’s. NOD mice lacking IL-27 signals, by either the cytokine IL-27p28 knock-out (KO) or
receptor IL-27Rα KO, are protected from developing lacrimal gland inflammation. Sjӧgren’s is defined as type I
IFN mediated autoimmune disease. IFNAR1 KO male NOD mice are protected from developing lacrimal gland
disease. Given the complex interplay between IL-27 and type I interferons, it is unknown if IL-27 contributes to
or augments the type I IFN response or if IL-27 can independently mediate the type I IFN-type response in this
model. The objective of this proposal is to elucidate the ability of IL-27 to drive IFN-like responses in NOD mice
in an IFN-dependent or independent manner and how that contributes to lacrimal gland autoimmunity. Our
central hypothesis is that IL-27 can drive an IFN response in NOD mice independent of IFN which contributes
to lacrimal gland inflammation. In my first aim, I will define the ability of DC derived-IL-27 to upregulate the IFN
signature associated with Sjögren’s-like disease in both DCs and T cells utilizing in vitro methods. In my
second aim, I will define the effects of IL-27 in a type I IFN-independent manner in a mouse model of
Sjögren’s utilizing an in vivo system. Upon completion of this study, I will have a greater understanding of the
role of IL-27 in promoting both IFN-dependent and -independent responses related to Sjӧgren’s. Defining these
early disease mechanisms will promote development of early diagnostic biomarkers, which will provide
opportunities for early interventions and potential therapeutic targets.

Public health relevance
PROJECT NARRATIVE Sjögren’s disease is a complex, chronic autoimmune disease that leads to severe dry mouth with complications due to poor oral health and severe dry eye disease with potential for vision-threatening complications. Despite being one of the most common autoimmune rheumatologic diseases, affecting up to 4 million Americans, the cause of Sjögren’s disease is unknown. The goal of this research is to define the mechanisms by which the immune system is driven to attack tear producing glands–the hallmark of Sjögren’s disease–which will lead to better early diagnostic tests and new treatments for this and other autoimmune diseases.